CGRP-CLR mediated regulation of bone healing

Periosteum, a primary site of the fracture healing response, is highly vascularized and densely
innervated. Studies on bone fracture have primarily focused on the role of growth factors and vascularization
in the healing process, but we postulate that sensory nerve signals are a critical part of the regulatory
mechanism that initiate the stem/progenitor cell responses required for fracture callus formation. A number of
lines of evidence point to sensory innervation, or signals associated with sensory nerves as promoters of
bone accrual and healing. For example, fracture healing is impaired following chemical sensory denervation,
but the sensory nerve-derived signals that promote healing as not yet defined. We hypothesize that damage
to sensory nerves in the periosteum orchestrates the bone-healing cascade through calcitonin gene-related
peptide (CGRP) – calcitonin like receptor (CLR) signaling. This is important given that multiple CGRP
inhibitors were recently approved by the FDA for prevention and treatment of migraines.
In Aim 1 we will evaluate the effects of CGRP inhibitors on bone healing. Given that CGRP plays a
role in bone turnover and potentially healing, it is important to understand the impact of CGRP inhibition on
fracture healing. In the Aim 2, we will determine which cell lineage or lineages responsive to CGRP signals
during healing using targeted deletion of the CLR receptor. CLR deletion in early fracture healing will be
targeted to the following lineages using inducible Cre’s: MPCs (αSMA-CreER), chondrocyte (Acan)-CreER,
osteoblasts using Col2.3CreER and in endothelial (Cdh5-CreER) during fracture healing. The effects on
callus formation and strength, as well as differentiation in the callus will be determined. We will examine
cellular mechanisms of CGRP/CLR action utilizing in vivo approaches to study MPC expansion, differentiation
and vascularization. We propose to dissect CLR signaling by distinguishing effects of the ligands. The main
ligands are CGRP and Adrenomedullin that act via CLR and RAMP, of which CLR-RAMP1 is main complex
for CGRP signaling while CLR-RAMP2 and RAMP3 is responsible for ADM signal activation. In Aim 3 we will
evaluate effects of ADM deletion in mesenchymal population using ADMfl/fl mice. We will also define
downstream signaling mechanism of CLR deletion in MSCs and endothelial cells using 10x genomics.
Our study will also provide critical information on the effects that newly approved inhibitors of CGRP
signaling exhibit on bone healing and what cellular mechanisms affect healing via CLR receptor Finally,
testing approaches to modulate CGRP/CLR sensory singling may lead to a therapeutic strategy to enhance
bone healing.

Public health relevance
CGRP inhibitors are now available for migraine prevention and treatment, so we will study the effects of chronic CGRP antagonism on bone healing. We aim to understand the cellular and molecular mechanism by which CGRP/CLR signaling can affect bone fracture healing. Understanding how CGRP/CLR sensory signaling influence fracture healing can pave the way for more targeted therapies for bone healing in the future.